CSR&D Research Career Scientist Award Application

Schizophrenia spectrum disorders and suicidal behavior are major public health problems affecting
Veterans. Each year, the VA provides care to approximately 100,000 schizophrenia patients, accounting for
nearly 12% of the VA’s total healthcare costs. At the same time, recent studies indicate that Veterans exhibit
higher suicide risk compared with the general U.S. population. The PI’s ongoing clinical cognitive neuroscience
research at the VA uses neuroimaging and psychophysiological approaches and primarily focuses on these
two areas: elucidating the neurobiology of schizophrenia and suicidal behavior. Identification of promising new
targets for intervention in schizophrenia and suicide prevention are critically important goals of the VA. The PI’s
track record of federal funding and peer-reviewed publications in these two areas has helped advance the field.
The PI’s new VA CSR&D Merit Award aims to identify the neural correlates and psychophysiology of normal
emotional reactivity and regulation in healthy control Veterans and pathological severity of emotion
dysregulation in Veterans with major depressive disorder (MDD) at low (non-suicidal psychiatric controls) and
high-risk (suicidal ideators and suicide attempters) for suicide. Participants receive baseline functional MRI
scans and a psychophysiological paradigm that provides a reliable, non-verbal, low-cost measure of emotion
processing (i.e. affective startle modulation). The psychophysiology session is repeated at a 6-month follow-up;
clinical symptom assessments are done at baseline, 6-, and 12-month follow-up. Understanding brain circuitry
anomalies underlying dysregulated emotional expression and psychological mediators that give rise to and
predict suicidal behavior and distinguish between ideators and attempters has clear public health importance.
This newly-funded VA Merit study promises to help uncover the mechanisms by which biological and
psychological factors give rise to suicidal behavior and may aid in prospectively identifying Veterans at greatest
risk for suicide.
The goal of the PI’s current schizophrenia-spectrum research (funded by her previous VA CSR&D Merit
Award) is to begin to translate pre-clinical scientific research in schizophrenia into the clinical arena. In order to
identify promising new targets for intervention in schizophrenia, a better understanding of its pathological
circuitry and underlying genetic susceptibilities is required. Her work uses diffusion tensor imaging (DTI) and
structural MRI to characterize white matter abnormalities in frontal-temporal regions. DTI fiber tractography
allows quantification of the integrity of white matter connectivity in the brain. Various susceptibility genes are
implicated in white matter abnormalities and schizophrenia (e.g., NRG1 and ERBB4). Together with her
multidisciplinary VA-Icahn School of Medicine at Mount Sinai (ISMMS) colleagues who bring expertise in
genetics, the PI’s work investigates a model of white matter disorganization in schizophrenia. Data are
currently being analyzed and published from her recent VA Merit study of 60 individuals with schizotypal
personality disorder (SPD) and 60 healthy controls who received MRI and were genotyped. This work
evaluates white matter organization and examines the relationship between white matter connectivity
(fractional anisotropy and tractography DTI measures), white matter volume (structural MRI), allelic variation in
two underlying susceptibility genes (NRG1 and ERBB4), and cognitive impairment/deficit symptoms across the
spectrum. SPD participants are studied as our choice of phenotype as they represent a form of schizophrenia
without the confounding artifacts of chronic antipsychotic treatment, long-term psychosis, and hospitalization.
Impact: This Research Career Scientist Award will allow the PI to augment her highly collaborative VA
research and mentoring of promising VA MIRECC fellows and clinician-scientists. The PI’s current VA Merit is
the first study at the JJPVAMC to conduct research 3T MRI scans. The PI’s goal is to further expand her MRI
research program in schizophrenia and suicidal behavior at the JJPVAMC.

Public health relevance
Schizophrenia (Sz) spectrum disorders and suicidal behavior are major public health problems affecting Veterans. Recent figures estimate that the VA treats ~100,000 Sz patients each year, accounting for nearly 12% of VA healthcare costs. Recent studies indicate that Veterans exhibit higher suicide risk compared with the general U.S. population. The PI’s ongoing clinical cognitive neuroscience research at the VA focuses on elucidating the neurobiology of Sz and suicidal behavior using neuroimaging and psychophysiological approaches. Suicide prevention and identification of promising new targets for intervention in Sz are critically important goals of the VA. The PI’s track record of federal funding and peer-reviewed publications in these two areas has helped advance the field and her current Merit Award may identify psychophysiological biomarkers which aid in prospectively identifying Veterans at greatest risk for suicide. This RCS Award will allow the PI to augment her highly collaborative VA research and mentoring of promising VA fellows and clinician-scientists.